A multi-level bias correction model for bulk and single-cell CUT&Tag data

Histone modifications (HM) and transcription factors (TF) are key factors in maintaining the cell identity by
regulating the type-specific gene expression program and chromatin structure. Both HMs and TFs can be
aberrantly regulated in the pathogenesis and are a major class of cancer cell dependencies. Precise detection
of HM and TF binding genome-wide is essential for a better understanding of transcriptional regulation.
Cleavage Under Targets & Tagmentation (CUT&Tag) is an easy and low-cost epigenomic profiling method that
can be performed on a low number of cells or even on the single-cell level. Thousands of CUT&Tag datasets
have been generated for profiling TF binding sites and HMs since the advent of this technique, providing a
valuable resource for functional genomics and disease research. CUT&Tag experiments rely on the
hyperactive transposase Tn5 for tagmentation. Tn5 is subject to intrinsic sequence insertion biases, and
enrichment of Tn5 captured reads toward chromatin accessibility regions also confound the distribution of
CUT&Tag reads, especially for factors with weak association with chromatin accessibility. Both features bring
great biases in the CUT&Tag data that confound the data analysis. For example, Strong CUT&Tag signal
enrichment of repressive histone modification H3K27me3 can be observed at actively transcribed gene
promoter regions where chromatin is openly accessible but no H3K27me3 signal from ChIP-seq, indicating that
the observed CUT&Tag signal is likely false positive. The high-sparsity characteristics of single-cell data
makes the intrinsic biases more substantial compared to bulk data, creating additional challenges in
computational modeling and data analysis. For example, the average Tn5 intrinsic cleavage bias level varies
across individual cells and confound the cell clustering result from single-cell ATAC-seq data, which carries
similar Tn5 intrinsic bias as CUT&Tag. Based on these preliminary observations and our group’s existing work,
we propose to develop computational models to accurately quantify both the open chromatin bias and the Tn5
intrinsic cleavage bias from CUT&Tag data on both bulk and single-cell levels. Using the new model to be
developed, we will characterize how open chromatin and intrinsic cleavage biases affect the detection of HM
and TF binding sites in both bulk and single-cell level CUT&Tag data. The bias correction model can be further
incorporated in existing or new bioinformatics methods to detect the HM/TF signals, for both bulk and single-
cell CUT&Tag data. this project focuses on developing a computational method for bias correction for
improving CUT&Tag data analysis. The proposed computational method complements existing bioinformatics
tools and will have broad applications in functional genomics and epigenomics research. The results from the
proposed work will fill the knowledge gap in single-cell studies of chromatin dynamics and transcriptional
regulation and could provide mechanistic insights for both basic science and translational studies.

Public health relevance
Project Narrative Accurate detection of protein-DNA interactions and chromatin marks in the genome is important for understanding the fundamental mechanisms of genome organization and gene regulation. Innovative assays such as Cleavage Under Targets and Tagmentation (CUT&Tag) have been developed to accurately measure such information in few cells or single cells. This project aims to develop innovative computational models to estimate and correct biases from CUT&Tag data for improved analysis and biological interpretation.